Facility Core A: Integrative Health Sciences

A. Overall Objectives and Specific Aims The overall goal of this facility core is to develop an infrastructure and an interactive environment to promote and facilitate productive collaborations among environmental health, population, basic, and clinical scientists, to test cutting edge hypotheses in integrative translational research on environmental disorders. This core will enhance access of all center members to populations, biospecimen repositories, services and data banks from population-based and clinical studies, thereby fostering these collaborations among scientists.